DEVELOPMENT OF SNOW CLEANING WITH SUPERCRITICAL CO2

A prototype instrument will be constructed to clean, sterilize, and enable fully viable reuse of tissue culture polystyrene (TCPS) vessels such as T-flasks.